COBRE in Sex-Based Precision Medicine

The Administrative Core (AC) of the Tulane Center of Biomedical Research Excellence in Sex-Based Precision
Medicine (COBRE in SPM) will perform functions critical to the ongoing success, sustainability, and growth of
our center. Specifically, the AC will oversee the mentoring plan for Research Project Leaders (RPLs) and Pilot
Project Leaders (PPLs), harmonize the components and activities of the COBRE, and foster interdisciplinary
collaborations and scientific opportunities. The specific aims of the AC are to 1) provide the administrative
infrastructure that will facilitate the successful performance of the Research Projects, Enrichment Program, Pilot
Project Program, and Sex-Based Precision Medicine Research Core (SPMRC). This includes assessing and
monitoring RPL/PPL–mentor interactions, evaluating the productivity and effectiveness of COBRE activities,
overseeing the decision-making process for continuous improvement of COBRE activities, and updating the
COBRE website; 2) oversee the execution of a Mentoring Plan for RPLs and PPLs to facilitate their transition to
and attainment of independent investigator status. The AC will enhance the effectiveness of research conducted
by RPLs by developing individualized Career & Scientific Mentoring Plans; assessing the mentoring process;
evaluating RPL progress toward research independence; and evaluating PPL progress toward becoming an
RPL; 3) oversee the process for selecting new RPLs by organizing the review by our Advisory Committee; 4)
oversee an innovative Enrichment Program composed of an SPM Curriculum integrated into undergraduate,
graduate, and medical classes; an SPM Bootcamp for RPLs and PPLs to lay SPM foundations by teaching
concepts and methods from which high-profile SPM research will emerge; an SPM Seminar Series; and an SPM
Workshop and annual Symposium; 5) support innovative clinical and translational research in SPM by
organizing, reviewing and funding Pilot Projects at the intersection of sex and gender with other genetic,
biological, and social determinants of health and leading to submission of successful new NIH proposals; 6)
oversee the functioning of a SPMRC to support RPLs, PPLs, and the University-wide research community in the
use of appropriate analytical approaches, biostatistical and bioinformatics analysis, experimental design and
data management, and its integration into the Enrichment Program; 7) grow a critical mass of SPM-focused
investigators and develop a pipeline for sustainability by working with Tulane leadership to recruit investigators
with relevant expertise in SPM and securing matching funds to extend and enhance the impact of the Pilot Project
Program. Our proposed leadership team — Franck Mauvais-Jarvis, MD, PhD (Director, MPI), Marie Krousel-
Wood, MD, MSPH (AC Co-Director, MPI), and Vivian Fonseca, MD (AC Associate Director and Pilot Project
Program Director), as well as Sarah Lindsey, PhD (Enrichment Program Director) and David Crosslin, PhD
(SPMRC Director) — will oversee the optimal performance of the COBRE in SPM.